IMAGINE: Intestinal Metaplasia And Gastritis INtErception Study

ABSTRACT
Infection with the common bacteria, Helicobacter pylori, is associated with a range of changes to the gastric
mucosa, resulting in conditions which can have significant effects on a patient’s morbidity and quality of life, in
addition to increasing risk of gastric adenocarcinoma. This proposal focuses on pre-malignant disease in the
stomach through clinically-relevant investigation of the synergy between H. pylori and host response in patients
with H. pylori infection and in gastric intestinal metaplasia (GIM). In clinical practice, H. pylori is only considered
as present or absent. However, H. pylori strain-specific factors such as cytotoxin associated gene A, CagA,
interfere with the host adaptive immune system to allow H. pylori colonization in gastric mucosa. In addition, H.
pylori strains may carry antibiotic resistance genes that contribute to treatment failure and persistence of the H.
pylori infection, a known risk factor for gastric cancer development. In this proposal, the IMAGINE: Intestinal
Metaplasia And Gastritis INtErception Study, we aim to address major knowledge gaps relating to molecular
information about H. pylori heterogeneity and the relationship to gastric mucosal changes and outcomes.
Specifically, we will focus on generating new knowledge that will result in more effective H. pylori eradiation and
new approaches to cancer interception in premalignant gastric disease through identifying factors associated
with disease progression in patients with GIM. Our preliminary data suggest that in patients infected with H.
pylori, higher bacterial load and antibiotic resistance are associated with increased risk of persistence. The
combination of exposure to the CagA virulence factor with life stress exposures including current life-stress as
well as adverse childhood experiences may be associated with risk of progression. We hypothesize that the
combination of infection with virulent H. pylori strains and stress exposures synergistically contribute to the
development of premalignant disease in the stomach. A strength of our research program is the establishment
of proven recruitment strategies that have allowed us to build racially diverse cohorts, collecting detailed survey
information as well as biospecimens, to study premalignant disease in a high-risk population. Our goal is to build
knowledge of premalignant gastric disease that will help us address the starkly disparate outcomes related to H.
pylori-infection in the US, given both increased rates of gastric cancer incidence and survival in Black patients.
Through this work, we are also generating a large bank of gastric organoids including GIM from a diverse patient
population. Our work is particularly relevant as current clinical guidelines for GIM recognize the racial differences
but offer no guidance on how to incorporate this or knowledge of other risk factors into clinical Indeed,
surveillance of GIM among any patients is currently not recommended and strategies for risk-stratification are
lacking. Deeper understanding of the role of H. pylori-specific factors and host response may allow for
personalized, precision H. pylori treatment as well as better screening and surveillance strategies for GIM, and
ultimately gastric cancer interception.

Public health relevance
PROJECT NARRATIVE Approximately 30% of all Americans are infected with Helicobacter pylori, a bacterium responsible for a range of gastric conditions, including ulcer, gastritis, atrophy, gastric intestinal metaplasia, and cancer, and yet significant knowledge gaps remain regarding how to best care for patients infected with this bacteria, and specifically how to integrate molecular information about strain into clinical care. Furthermore, host response to H. pylori also affects the outcome of the infection, and our preliminary data suggest that stress exposures such as adverse childhood experiences and low socioeconomic status may be associated with poor outcomes. We hypothesize that the combination of infection with virulent H. pylori strains and stress exposure synergistically contribute to the development of premalignant disease in the stomach.